Organ Specific Project

PROJECT ABSTRACT
The overarching goal of the Human BioMolecular Atlas Program (HuBMAP) and specifically of Tissue Mapping
Centers is to generate high resolution 3D biomolecular maps for non-diseased human organs. The overall
objective of this pancreas organ specific project (OSP) is to identify and collect whole disease-free pancreas
from donors across different sexes and ethnicities, to develop a robust system for tissue processing and
distribution, and to generate multi-scale, high resolution, 3D multi-omics molecular atlases of functional
regions of human pancreas.
This OSP integrates unique expertise ranging from pancreas biology, diabetes, organ procurement, tissue
processing, deep-tissue fluorescence imaging analysis (University of Florida), advanced multi-omics mass
spectrometry-based tissue mapping (PNNL), and sophisticated high-throughput bioinformatics and 3D
reconstruction of molecular maps (Texas Advanced Computing Center) of regions of pancreas, such as islets.
Specifically, we will: (1) Identify and collect whole disease-free pancreas from donors through collaboration
with the Organ Procurement Organizations (OPO) and Research Intermediaries (RI), and develop
infrastructure for timely referral and donor collection, as well as a robust, web-based, specimen inventory and
request system that accesses a catalogue of representative sample derivative meta-data (i.e. whole slide image
or cytometry) of quality and composition; (2) Provide preserved, embedded, and sectioned pancreas tissue
using pancreatic processing processes that have carefully mapped the pancreas in 2D; (3) Perform multi-scale
and multi-omic imaging or spatially resolved characterization of pancreas and function-guided tissue sections
through the characterization pipeline; and (4) Create comprehensive 3-D biomolecular atlas of pancreas that
maps protein, metabolite, and lipid expression throughout functional regions of the pancreas through the Data
Analysis Core.